Neutralization studies of SARS-CoV-2 with variant S proteins

To evaluate a large panel of SARS CoV-2 S protein variants for their effect on virus susceptibility to neutralization by a panel of neutralizing antibodies and sera from vaccine recipients